Gut Microbiome and Salivary Gland Function: Protective Actions & Key Players

PROJECT SUMMARY
Salivary gland function is chronically impaired in Sjӧgren’s syndrome, an autoimmune exocrine gland disease
with no cure or effective treatment available. Aberrantly activated innate immune cells, autoreactive T- and B
cells, and proinflammatory cytokines collectively cause Sjogren’s-characteristic salivary gland inflammation and
dysfunction. There is an urgent need for novel, effective therapies that protect/improve salivary gland function
and ameliorate salivary gland inflammation. The importance of host gut microbiome in health and disease is
increasingly recognized, yet very little is known about the impact of gut microbiome on salivary glands, especially
the protective bacteria and their actions. Hence, the main objective of this project is to address this knowledge
gap, with a particular focus on identifying the potentially salivary gland-protective gut bacteria and revealing their
precise actions using both murine models and cells and samples from Sjӧgren’s disease patients. Our
preliminary studies showed that transplant of fecal bacteria from healthy C57BL/6 mice to the non-obese diabetic
mice, a spontaneous model of Sjӧgren’s syndrome, exerted a protective effect on salivary glands. The protection
was accompanied by reduced inflammatory responses and diminished expression of bromodomain containing
2, an epigenetic reader/modulator, in salivary gland epithelial cells. We also identified multiple specific bacterial
species with salivary gland-protective potentials based on our preliminary microbiome analyses and the pertinent
evidence from human studies in the literature. We formed the central hypothesis that healthy gut microbiota
contains bacterial species that, acting through their metabolites, protect salivary gland function by mitigating
inflammatory responses and dysfunction of salivary gland epithelial cells through mechanisms including
downregulating the expression of epigenetic reader of bromodomain containing 2. Aim 1 of this project will
define and discover the mechanisms underlying the protective effects of healthy C57BL/6 fecal microbiota
transplant on salivary glands in the non-obese diabetic mice and a second, induced model of Sjӧgren’s
syndrome. Aim 2 will explore the protective impact of specific gut bacterial species on salivary gland function
in the two mouse models. Aim 3 will identify and test microbial metabolites that may mediate the salivary gland-
protective impact of gut microbiota using both mouse SS models and cells/samples from human Sjӧgren’s
disease patients. The project will employ a combination of sophisticated immunological, microbiological and
systemic biological methodologies, including 16S rRNA gene sequencing analysis of microbiome, RNA-
sequencing analysis of host cells, and metabolomic assays. Knowledge generated will have direct relevance to
and impact on human health, and will advance the development of novel, gut microbe/microbial metabolite-
based therapies to combat autoimmune Sjӧgren’s disease as well as other salivary gland inflammatory disorders.

Public health relevance
Project Narrative Salivary gland function is chronically impaired in Sjӧgren’s syndrome, a challenging autoimmune exocrine gland disease affecting 4 million Americans with no cure or effective therapies available. There is an urgent need to develop effective and targeted new therapeutic approaches to protect and improve salivary gland secretory function in these patients. Completion of this research project will generate critical new knowledge and insights for the development of novel, microbiome- and microbial metabolite-based therapies to prevent and treat salivary gland hypofunction caused by Sjӧgren’s syndrome and other disease conditions, thereby improving the oral and systemic health of millions of people.